EFFECTS OF EXERCISE ON CHYLOMICRON AND CHYLOMICRON REMNANT METABOLISM

The effect of exercise training and of an acute bout of exercise on chylomicron and chylomicron remnant metabolism will be studies in trained athletes before and after a 2 week sedentary period and immediately after a bout of exercise. Hypoprotein concentrations and 24 hour profiles of lipids will be measured.